SIDS, failed autoresuscitation, and a novel serotonergic brainstem-cerebellar circuit

The Sudden Infant Death Syndrome (SIDS) remains the leading cause of death in the post-neonatal period.
Rare traces from infants who died of SIDS indicate cardiovascular collapse during autoresuscitation, the
integrated cardiovascular and sympathetic response necessary to sustain life in severely hypoxic conditions.
There is evidence of serotonergic dysfunction in SIDS, including reduced serotonin (5-HT) and reduced 5-
HT2A receptors across multiple regions necessary for autoresuscitation. Most SIDS infants have reduced 5-
HT2A receptors within the nucleus of the solitary tract (NTS) and medial accessory olive (MAO). Along with the
fastigial nucleus of the cerebellum (FN), the NTS and MAO are key components of a brainstem-cerebellar
circuit that increases drive to the rostral ventrolateral medulla (RVLM). Ultimately, the activation of the NTS-
MAO-FN-RVLM circuit augments sympathetic activity, a response necessary for heart rate and blood pressure
recovery from severe hypoxia. The MAO is the sole source of climbing fibers to Purkinje cells (PCs); the latter
provide critical neuromodulation to the FN. Prenatal and/or postnatal intermittent hypoxia (IH) are associated
with key risk factors for SIDS. IH may compromise autoresuscitation by inducing damage to vulnerable MAO
and PCs while also reducing 5-HT2A activity across the entire circuit. Our overarching hypothesis is that an
important subset of SIDS infants has reduced drive through 5-HT2A receptors within the NTS-MAO-FN-
RVLM circuit. Prenatal or postnatal IH damages the MAO, PC cells, and reduces serotonergic function,
compromising the ability of the circuit to restore blood pressure during autoresuscitation, resulting in
sudden death. To test these hypotheses, we use a combination of delicate DREAD- and pharmacological-
based experiments that manipulate serotonergic inputs to the NTS-MAO-FN-RVLM in infant rats, assessing
the extent that drive through 5-HT2A receptors is necessary and sufficient for cardiovascular recovery and
survival during autoresuscitation. Rodent studies run in parallel with studies using tissue from SIDS infants and
controls. For the first time we examine 5-HT receptor binding and expression in the cerebellum, as well as the
integrity of PCs and climbing fibers in SIDS versus controls. The proposed studies are innovative
experimentally and conceptually – in particular, the cerebellum's role in successful cardiovascular recovery in
autoresuscitation has never been tested experimentally. We pair rodent and human studies to maximize the
potential for translational outcomes and clinical impact. From our studies will emerge a new concept that
reduced drive through 5-HT2A receptors within a key brainstem-cerebellar circuit underlies a significant
proportion of SIDS deaths. The knowledge generated will potentiate the development of key biomarkers and
prophylactic strategies to reduce SIDS incidence worldwide. This research therefore aligns with the mission of
the National Heart Lung and Blood Institute to support research promoting the prevention and treatment of
heart, lung, and blood diseases to enhance the health of all individuals.

Public health relevance
The Sudden Infant Death Syndrome (SIDS) remains the leading cause of infant death in the post-neonatal period, despite the adoption of safe sleep practices. SIDS infants have defects in the serotonin system of the brain and experience severe hypoxia (i.e., low oxygen) and cardiovascular collapse just before death. The proposed research will reveal how an under-studied brainstem-cerebellar circuit, facilitated by serotonin, helps an infant recover cardiovascular function during severely hypoxic conditions.